Negative and positive feedback in cell signaling

PROJECT SUMMARY (from the parent grant)
This is an application for the Administrative Supplements for Equipment Purchases for Select NIGMS-
Funded Awards program, for a BMG CLARIOstar Plus plate reader. A 96-well plate reader is needed for high
throughput cellular activity assays, which are performed almost daily and have been a component of nearly all
of our publications for the past two decades.
Over the past half century scientists have learned much about how cells detect hormones, nutrients
and other chemical cues. Typically, these signals are detected by a G protein-coupled receptor and are
transduced by a chemical second messenger, such as cAMP or calcium. Our lab has long focused on the
identification and characterization of feedback regulators, most notably RGS proteins. Whereas receptors
activate G proteins, RGS proteins inactivate G proteins through accelerated GTP hydrolysis.
In the next five years our lab will focus on the identification and characterization of novel second
messengers and their roles in two aspects of signal coordination. The first is focused on signal coordination by
a pheromone GPCR and by another GPCR that detects nutrients. The second is how the pheromone GPCR
regulates nutrient availability, through autophagy and the recycling of molecular building blocks.
This new initiative builds on our discovery that G proteins regulate, and are regulated by, physiological
changes in intracellular pH and of 2-hydroxy branched chain amino acids. These metabolites are second
messengers of glucose limitation and osmotic stress, respectively, and share the ability to trigger G protein
phosphorylation and inactivation.
Our overall approach is to systematically determine the effects of stimulating (pharmacologically) the cell,
deleting (genetically) signaling pathway components, measuring (NMR and mass spectrometry) changes in
cellular proteins and metabolites, reconstituting (biochemically) the activity of G proteins and effector kinases,
and solving (x-ray and NMR) the structures of second messengers bound to their physiological targets.
If successful, our research program will lead to the identification of novel second messengers, their
mechanism of action, and their functional consequences in the cell. Our investigations will require the
implementation of multiple research platforms and strategies, and thus benefit greatly from the flexibility and
stability provided by the MIRA program.

Public health relevance
PROJECT NARRATIVE (from the parent grant) Hormones and neurotransmitters, as well as most pharmaceuticals, do not act in isolation but are subject to feedback regulation and cross-talk from other signaling pathways, including those that sense nutrients such as glucose. Our long term objective is to understand how cells respond to hormones under changing physiological circumstances and to predict how those circumstances affect pharmacological responses.